DEVELOPMENT OF A WEB-BASED INFORMATICS PLATFORM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The intent is to construct, from scratch, a centralized, web-based informational management and retrieval tool utilizing open-source industry standards for WWW development. This includes the ability for all groups of the YRC and collaborators to be able to access, change and analyze relevant data, with access control based on the YRC group and/or project membership.